A "humanized" mouse model of Glut1 deficiency syndrome.

Project Summary
Relative to its size, the human brain consumes a disproportionately large quantity of the body’s total energy
needs. This energy, delivered mainly in the form of glucose, must be readily available and supplied to the
brain on-demand. Failure to do so has dire consequences for the organism, resulting in a state of
neuroglycopenia and, in severe instances, coma and death. While the overt consequence of chronic
neuroglycopenia – cognitive dysfunction – is easily recognized and well-established, its cellular and molecular
correlates are yet to be fully defined. One way of gaining an understanding of the mechanistic details
underlying brain energy deprivation is through the study of genetically determined brain energy failure
syndromes. Glucose Transporter-1 deficiency syndrome (Glut1 DS) is the quintessential example. Caused by
low levels of the principal glucose transporter (Glut1) of the brain, the disease strikes mainly in infancy or early
childhood and is characterized by severe epileptic seizures, low brain glucose, cognitive dysfunction and a
complex movement disorder that worsens with age. Yet, there is no truly effective treatment that addresses
the root cause of Glut1 DS, and little understanding of the molecular and cellular mechanisms that account for
the phenotypic presentation of the disease. We wish to address these deficiencies, and propose to do so
through the development of novel “humanized” Glut1 DS model mice harboring the entire human Glut1 locus –
the objective of this proposal. Preliminary work has already resulted in several lines of these mice. During the
project period, we will thoroughly characterize the mice, employing a battery of well-established molecular,
cellular and behavioral assays that we have optimized in the lab. A successful outcome to the project will result
in an invaluable tool to probe basic mechanisms underlying not just Glut1 DS but also the larger family of brain
energy failure syndromes. Moreover, the mice are expected to prove useful in Glut1 DS therapy development;
raising Glut1 levels is an intuitively appealing therapeutic strategy and agents that have the potential to do so
are best tested in an in vivo model endowed with the human Glut1 gene.

Public health relevance
Project Narrative Understanding the molecular and cellular basis of brain energy deprivation is important in health and in disease, and can fortunately be studied in the context of the single-gene disorder, Glut1 Deficiency Syndrome (Glut1 DS). This project centers on the creation of a novel “humanized” mouse model of Glut1 DS, one that will serve as a tool to enhance our understanding of brain energy failure and for therapy development.